Cardiovascular Phenotyping Core B

CARDIOVASCULAR PHENOTYPING CORE B SUMMARY
The primary goal and function of Core B is to provide services to the individual projects within the Program
Project related to measures of cardiovascular function. The objective of Core B is to serve basic support
services separated into three functional areas: 1) 24-hour blood pressure analysis in rodent models; 2)
ambulatory and clinic blood pressure measurements and validation in human participants; and 3) pulse wave
velocity and pulse wave analysis assessments in human subjects. We will also monitor quality control and
reproducibility in cardiovascular measurements in both animal models and human subjects for maximum
efficiency and rigor. Core B is structured to provide the highest degree of quality control and allow for
consistency across all of the individual projects of the Program Project. This involves very closely coordinated
efforts and sharing of expertise between the projects. Drs. David Pollock and Eric Judd will oversee Core B.
Dr. Pollock has many years of experience coordinating large scale in vivo studies in rodents with over 20 years
of conducting chronic blood pressure measurements by telemetry. Dr. Judd has directed a wide range of
cardiovascular phenotyping studies in human subjects for over 10 years. This includes ambulatory blood
pressure monitoring, vascular stiffness measurements via pulse wave velocity and pulse wave analysis. Core
services will be tightly maintained with weekly contacts by email and monthly meetings to discuss how well
Core B is functioning to meet the needs of the PPG and any issues that may have developed. The aims of
Core B are: 1) Provide circadian analysis of 24-hour telemetry data in rodent models, 2) Provide frequency and
time domain analysis for assessment of autonomic function in rodent models, 3) Provide supervision of clinic
and ambulatory blood pressure measurements and consistent data acquisition and analysis, 4) Perform pulse
wave velocity assessments, 5) Liaison with Core C to provide statistical analysis of cardiovascular data, and 6)
Liaison with Core A to facilitate data storage.

Public health relevance
CARDIOVASCULAR PHENOTYPING CORE B NARRATIVE The Program Project focuses on elucidating mechanisms by which stress early in life contributes to the serious health problem of cardiovascular risk later in life. The Cardiovascular Phenotyping Core will be critical for providing individual projects within the Program Project expertise and support services regarding: 1) 24-hour blood pressure analysis in rodent models; 2) ambulatory and clinic blood pressure measurements and validation in human participants; and 3) pulse wave velocity and pulse wave analysis assessments in human subjects.